Physical Biology of Transcriptional Control in Embryonic Development

Project summary/abstract
The correct implementation of developmental programs depends on information encoded in an organism’s
DNA. Mutations in these regions that control genes have been shown to be responsible for ailments such as
developmental defects and cancer. While great progress has been made in mapping these regulatory regions
and uncovering how their target genes interact with each other, it is still not possible to precisely predict
patterns of gene expression in space and time from knowledge of the DNA regulatory sequence of multicellular
organisms. The overarching goal of the proposed work is to leverage knowledge about these regulatory
regions and the transcription factors that bind to them in order to reach a predictive understanding of the
developmental program of the early embryo of the fruit fly Drosophila melanogaster. Armed with recent
innovations in (1) theoretical models that predict the mean and variability in gene expression as a function of
regulatory sequence and input transcription factor concentration dynamics, and (2) technology to visualize and
quantify transcriptional initiation in real time in live, single cells in a fruit fly embryo, the proposed investigations
will achieve significant progress toward predictive understanding of transcriptional regulation in development.
First, through cycles of experiments and modeling, the proposed studies will uncover how pioneer transcription
factors dictates transcriptional onset dynamics by regulating chromatin accessibility to activators and
repressors. Second, an experiment–theory discourse that leverages synthetic biology will be used to reach a
predictive understanding of how the number, placement and affinity of transcription factor binding sites dictates
the rate of transcriptional initiation. Finally, we will focus on single-cell transcriptional dynamics and its
characteristic transcriptional bursts in order to shed light on the molecular mechanisms underlying transcription
and its control. Specifically, we will use our novel compound-state Hidden Markov model to determine whether
Dorsal controls burst size, frequency, amplitude, or some combination thereof, in order to generate hypotheses
about the mechanisms of action of this activator and determine whether stable clusters of high Dorsal
concentration that we recently discovered play an active role in regulating transcriptional dynamics. These
investigations will fuel the theory–experiment dialogue necessary for reaching a predictive understanding of
developmental decision-making. I envision that, by revealing the dynamic molecular mechanisms underlying
transcriptional control, we will be able to write governing equations for gene regulation and, ultimately,
engineer cellular decision-making programs for bioengineering and therapeutic purposes.

Public health relevance
Project Narrative Although the revolution in DNA sequencing in the last 20 years has transformed our understanding of how life operates, we are still discovering the many ways that healthy and diseased states arise from how cells “decide” to make proteins from DNA sequences. The work proposed here combines experiment, theory, and computation to reveal—across scales—how these “decisions” are made in the embryo of the fruit fly, a powerful model system for developmental biology. The proposed investigations will set the stage for the predictive bioengineering of multicellular organisms and future precision therapeutic tools for repairing developmental defects and halting states of unchecked cellular proliferation in cancer.